CCSG Supplement: Early-stage Surgeon Scientist Program (ESSP) - Chibawanye Ene

SUMMARY AND ABSTRACT
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as NOT-CA-
21-100.
Glioblastoma (GBM), the most common primary brain tumor in adults has a median survival of only 14.6months
despite aggressive surgery, radiation and chemotherapy. This outcome has not changed in the past 20 years as
many of the newer targeted therapies and even immunotherapies, which have been highly effective in other
cancers, have proven ineffective in GBM. Delta-24RGD oncolytic virus is a form of immunotherapy that has
shown efficacy with complete responses in 15% of GBM patients (or long-term survivors) as part of a clinical trial
performed here at MD Anderson Cancer Center. Short term survivors, however, showed no clinical response
following Delta-24RGD oncolytic virus treatment. Virally induced anti-glioma CD8+ T-cell responses were
observed in some long-term survivors following treatment, indicating that Delta-24RGD elicits an ant-tumor
immune response in GBM. It is unclear why short-term survivors lacked an anti-tumor immune response. Recent
studies have shown that patients with GBM have some of the highest levels of circulating immunosuppressive
myeloid cells, particularly PD-L1+ myeloid-derived suppressor cells (MDSCs), and that the levels of these PD-
L1+ immunosuppressive myeloid cells correlate with poor outcomes in GBM patients receiving immunotherapies.
Our preliminary data showed that Delta-24RGD oncolytic virus long term survivors have higher levels of the
potent polyfunctional and anti-tumor T-cell sub-population in circulation after treatment. It remains unclear
whether immunosuppressive PD-L1+ MDSCs modulate the levels of polyfunctional T-cells resulting in a lack of
expansion following Delta-24RGD oncolytic virus treatment especially in short-term survivors. We hypothesize
that circulating immunosuppressive myeloid cells inhibit circulating T-cell activation and polyfunctionality
resulting in resistance of GBM patients to Delta-24RGD oncolytic virus. To assess our hypothesis, we will
compare the levels of PD-L1+ MDSCs in Delta-24RGD responders to non-responders. In a mouse GBM model
that re-capitulates the high levels of PD-L1+ MDSCs in circulation, we will evaluate whether Delta-24RGD
oncolytic virus is more effective following selectively depletion of circulating PD-L1+ MDSCs. Finally, we propose
a therapeutic strategy to overcome systemic myeloid mediated immunosuppression by administering genetically
modified macrophages expressing T-cell activating cytokine IL-12 prior to Delta-24RGD oncolytic virus
treatment.

Public health relevance
NARRATIVE Our clinical trials have shown that Delta-24RGD oncolytic viruses induce complete response in only about 15% of recurrent glioblastoma patients. This proposal evaluates whether a specific subset of immunosuppressive circulating myeloid cells inhibit an anti-tumor T-cell immune response following treatment with Delta-24RGD oncolytic viruses. To overcome this T-cell immunosuppression, we propose administering genetically modified macrophages expressing T-cell activating cytokines prior to treatment with Delta-24RGD oncolytic virus.